A Career Development Award in AI-Assisted Ultrasound for Early Pregnancy Localization

PROJECT SUMMARY/ABSTRACT
A Career Development Award in AI-Assisted Ultrasound for Early Pregnancy Localization
This research addresses the challenge of evaluating women in early pregnancy presenting with signs and
symptoms concerning for ectopic pregnancy, particularly in resource-constrained settings where access to pelvic
ultrasound is limited. Despite pelvic ultrasound being the diagnostic mainstay for pregnancy localization, many
low- and middle-income countries and rural areas of the United States face substantial barriers to this technology,
owing to the high cost of equipment and need for trained staff. Consequently, ectopic pregnancy diagnosis may
be missed or delayed, increasing maternal morbidity. Importantly, diagnosis of an intrauterine pregnancy
effectively eliminates the possibility of an ectopic pregnancy, and achieving this diagnosis with transabdominal
pelvic ultrasound reduces the need for transvaginal pelvic ultrasound assessment. This proposal outlines an
innovative strategy to evaluate women presenting with non-specific symptoms of ectopic pregnancy. Point-of-
care ultrasound (POCUS) devices offer a cost-effective alternative to traditional cart-based machines. Novel
ultrasound collection procedures enable providers without formal ultrasound training to conduct evaluations. And
deep learning artificial intelligence (AI) models analyze sonographic data to make diagnoses. My long-term
career goal is to become an independent investigator leveraging evolving AI and ultrasound technology to
improve obstetric outcomes. To achieve my career goals and objectives, I need additional mentorship and
training in (i) applied data science with a focus on deep learning, (ii) clinical trials design and implementation,
and (iii) research communication and collaborative global health partnerships. I will leverage this training and the
resources of my mentors to achieve my scientific objective: to develop a novel strategy to evaluate early
pregnancy localization using advancements in deep learning and ultrasound technology. I will pursue this
objective through three specific research aims: (1) develop an AI ultrasound tool using transabdominal POCUS
“blind sweeps” to diagnose intrauterine pregnancy; (2) develop an AI ultrasound tool to a) guide a clinician with
minimal training to perform transvaginal ultrasound assessment and b) diagnose intrauterine and extrauterine
pregnancy; and (3) pilot the use of these AI ultrasound models to localize early pregnancies in women presenting
with signs and symptoms of ectopic pregnancy in both Lusaka, Zambia and Chapel Hill, North Carolina. I am
well-positioned to achieve these aims given the vast institutional resources available to me through the University
of North Carolina at Chapel Hill, along with an internationally-renowned team of mentors and advisors, including
Drs. Jeffrey Stringer and Michael Kosorok, who have a history of collaboration in the burgeoning field of AI-
assisted obstetric ultrasound. The proposed research is innovative and significant, and the results have the
potential to significantly improve the diagnostic evaluation of ectopic pregnancy in the most vulnerable pregnant
populations.

Public health relevance
NARRATIVE Ectopic pregnancy is a common, life-threatening early pregnancy complication. Diagnosis necessitates early pregnancy localization, which is difficult to reliably determine without pelvic ultrasound. This study aims to develop an innovative AI-assisted ultrasound strategy to localize early pregnancy, overcoming many traditional barriers to pelvic ultrasound access in resource-constrained settings.